AT/AZ COMPARED TO TMP/SMX IN PREVENTION OF BACTERIAL INFECTIONS/HIV

This study proposes to compare the combination of atovaquone and azithromycin to TMP/SMX in relation to adverse effects and incidence of serious and non-serious bacterial and opportunistic infections.